Implementing depression and adherence treatment in S. Africa HIV care

PROJECT SUMMARY
Background: Evidence-based treatments for depression and treatment adherence in persons with HIV
(PWH) are not reaching a sufficient number of PWH who need them, and untreated depression may hinder all
aspects of the HIV care cascade; especially rates of viral suppression. This is particularly dire in South Africa,
which has the highest number of HIV cases in the world,1 comorbid depression is approximately 30%, and only
0.28 psychiatrists and 0.32 psychologists per 100,000 people are available.2 Prior work: We developed
cognitive behavioral therapy for adherence and depression (CBT-AD) and found it to be efficacious and
effective for treating depression and improving ART adherence.3–8 In SA specifically, we demonstrated superior
effects of CBT-AD on depression, adherence, and viral undetectability in an task-shared effectiveness study
with nurse interventionists.9 CBT-AD was also cost-effective in this context.10 Design. This is a proposal for a
two-arm hybrid type 3 effectiveness-implementation study using a clinic randomized parallel cluster RCT
design. Across 10 clinics, we will compare a core set and enhanced set of implementation strategies to
increase the reach of evidence-based treatments to patients with HIV and depression in South Africa (SA). The
proposed strategies and outcomes are based on our Implementation Research Logic Model (IRLM)11 which we
developed from our preliminary community-engaged work in SA. Our IRLM links key determinants to
implementation strategies from the Expert Recommendations for Implementing Change (ERIC).12
Implementation Strategies and Outcomes: In both study arms, core strategies include expanding the nurse
cadre role, trainings to decrease mental health stigma, training in depression and depression screening,
education about existing evidence-based depression treatments (including our flip-book treatment manual for
CBT-AD, and referring patients to available evidence-based depression treatments - therapy or
psychopharmacotherapy). In the enhanced arm, strategies also include providing more resource-intensive on-
site training, “train-the-trainer” strategies in CBT-AD, and clinical supervision of the nurse interventionists for
one year. Using the RE-AIM framework,13 the primary implementation outcome is “reach”, the proportion of
patients who start an evidence-based treatment for depression (i.e., CBT-AD and/or psychopharmacotherapy),
though we will also examine, effectiveness, adoption, implementation, and maintenance. Effectiveness
outcomes are the percent of patients who show clinical improvement in depression and the percent who attain
viral undetectability within one year. Finally, we will compare high and low reach clinics to further inform
tailored implementation strategies for uptake and maintenance. Impact: CBT-AD is the only treatment that
impacted both HIV and depression outcomes in a prospective trial, has been task-shared in the S. African
context, is cost-effective, and has a set of implementation strategies based on community partnerships and our
prior work. The proposed study will provide a replicable implementation model.

Public health relevance
PROJECT NARRITIVE There is a global mental health crisis that is particularly problematic in the context of HIV in high impact settings where there is low reach of evidenced based mental health treatments. Based on our successful prior efficacy and effectiveness work with cognitive-behavioral therapy for adherence and depression (CBT-AD) in HIV, the current study is designed to identify replicable implementation strategies to enhance the reach of depression / adherence treatment in people living with HIV in S. Africa. If successful, the model can inform policy, funding decisions for HIV treatment delivery, and be extended to other low-resource settings for HIV and, potentially, other integrated medical/mental health settings and contexts.